Sex-specific arrhythmogenic mechanisms of atrial fibrillation

PROJECT SUMMARY: Atrial fibrillation (AF) is the most common cardiac arrhythmia worldwide, significantly
contributing to ischemic strokes, increased morbidity, and mortality. Despite its prevalence, AF
pharmacotherapy remains limited by poor efficacy and severe side effects, particularly in female patients, who
experience greater mortality and more severe AF-related symptoms than male patients. The mechanistic basis
for these sex differences in atrial electrophysiology (EP) and arrhythmia susceptibility is poorly understood due
to the underrepresentation of female subjects in clinical and preclinical cardiovascular research. This project
aims to address this critical knowledge gap by developing the first biophysically detailed, sex-specific
computational models of human atrial myocytes and tissues. These models will incorporate sex-specific ion
channel profiles, calcium handling properties, and structural differences in atrial tissue, informed by multi-level
experiments in human atrial myocytes and trabeculae from male and female patients in normal sinus rhythm
and with chronic AF. The acute and chronic effects of sex hormones will be determined though optical mapping
experiments in rabbit atria. The combined experimental and modeling design will test the central hypothesis
that AF-induced remodeling of ion channels, calcium handling proteins, and tissue architecture is delayed in
females due to estrogen's protective effects, but once remodeling occurs, the consequences are more severe
in females, contributing to higher arrhythmia vulnerability. Aim 1 will focus on revealing sex-specific
mechanisms of atrial EP and calcium handling that underlie arrhythmia vulnerability. Computational models of
male and female atrial cells and tissues will be developed and validated against experimental data from male
and female patient samples with and without AF. Aim 2 will investigate the contribution of sex hormones,
particularly estrogen and testosterone, to sex-based differences in atrial EP and arrhythmia risk. Using a
combination of experimental and computational approaches, we will simulate hormone fluctuations during
different physiological states and test how these variations impact arrhythmia susceptibility. Aim 3 seeks to
identify new sex-specific anti-AF strategies by using the computational models to simulate and optimize drug
therapies. We will test the hypothesis that targeting sex-specific AF mechanisms in combination, such as ion
channel blockade and calcium release modulation, can reduce arrhythmia risk more effectively than current
monotherapy one-size-fits-all treatments. This work will provide novel mechanistic insights into sex differences
in AF, highlighting the importance of considering sex as a biological variable in cardiovascular research.
Ultimately, these findings are expected to guide the development of personalized, sex-specific AF therapies,
improving treatment outcomes and reducing AF-related health disparities between male and female patients.

Public health relevance
PROJECT NARRATIVE: Atrial fibrillation (AF), the most common cardiac arrhythmia, affects about ~1-2% of the general population. A complex, progressive disease, it sharply increases the risk of stroke and often coexists with and worsens other severe cardiac diseases, particularly heart failure. While males are more likely to experience AF earlier in life, females with AF suffer from worse symptoms and generally fair worse than males. This project aims to achieve a better understanding of the sex-specific mechanisms underlying AF via new research tools, including state-of-the-art computer models, which will ultimately lead to improved treatments and outcomes for patients of all sexes.